A point of need clinical chemistry and hematology platform for improving accessibility to diagnostic testing

PROJECT SUMMARY
Complete blood counts and a basic metabolic panel are the most ordered blood tests in nearly all clinical settings.
These tests are predominantly conducted on expensive high-throughput instrumentation in centralized or well-
equipped satellite laboratories. Currently, there is no cost-effective and efficient instrumentation that can conduct
these tests at the point-of-need or in clinics that do not have access to centralized testing facilities. The
development of clinical instruments that can increase access to testing and provide clinicians with earlier,
actionable diagnostic tests results have significant potential to improve healthcare management in a variety of
clinical settings including rural and low resource settings, pediatric and neonate testing, and urgent and primary
care settings. Critically, in many of these settings, healthcare personnel can be limited. In these settings
phlebotomists or other trained personnel required for blood draws and clinical testing are not typically present.
Consequently, there is a need for diagnostic testing instrumentation that can improve the accessibility of testing
in various healthcare settings. Critically, this instrumentation requires ease of use, including CLIA waiver status,
while providing performance that is comparable to standard testing in centralized laboratory settings. However,
there are no solutions available that meet this need. To address this need, General Fluidics has developed the
Axess System, which is a unique, rapid, cost-effective, and high-performance point-of-need solution that
combines comprehensive clinical chemistry and hematology testing into a single modular platform delivering
results in 15 to 20 minutes. The Axess system has been validated with venous whole blood for hematology and
plasma derived from venous blood for clinical chemistry testing. In this proposal, the Axess system will be
validated using fingerstick (i.e., capillary blood), where performance equivalence with venous blood would
support use of the Axess systems in clinical settings where phlebotomists are not present. This would support
further optimization and commercialization of the Axess system with a FDA CLIA waiver, which would deliver
the first comprehensive instrument with central laboratory performance that could be used at the point-of-need.
General Fluidics has previously validated a basic metabolic panel and a complete blood count through clinical
performance evaluation studies at Massachusetts General Hospital and in-house evaluations. The goal of this
Phase I project will be to demonstrate equivalence for hematology and clinical chemistry testing that is performed
on the Axess System with de-identified matched capillary and venous blood specimens.

Public health relevance
PROJECT NARRATIVE The development of comprehensive point-of-need analytical instrumentation that is easy to use (CLIA waiver), cost-effective, and high performance has significant potential to improve the access to diagnostic testing in a variety of underserved healthcare settings including rural and low-resource settings, pediatric and neonate clinics, and many urgent and primary care facilities. General Fluidics has developed the Axess System which uses venous blood and delivers performance comparable to centralized testing capabilities in a rapid, modular, point-of-need instrument. The goal of this proposal will be to demonstrate performance equivalence in venous and capillary blood specimens to support future CLIA waiver and to improve the accessibility of diagnostic testing.